Incentivizing Better Quality in Long-Term Care

DESCRIPTION (provided by applicant): Project Summary/Abstract State Medicaid programs have been at the forefront of value based purchasing and other policy initiatives to incentivize better long-term care quality. (Arling et al., 2009; Briesacher et al., 2009; Miller et al., 2013; Werner et al., 2009). These programs link Medicaid payment to nursing home performance on standardized quality measures, fund provider-directed quality improvement projects, or offer a bonus for exemplar facilities meeting high quality standards. Indiana University Center for Aging Research and Minnesota Department of Human Services propose to sponsor an invitational, one and one-half day conference on long-term care value based purchasing for 50-75 state policy makers, long-term care researchers and other stakeholders. The primary purpose of the conference is for research and development: to develop health services research agendas and identify strategies and mechanisms for studying them. Secondarily, we will: (a) disseminate and implement health services research information and tools for formulating or evaluating health policy, and for managing health care programs; and (b) develop partnerships with stakeholder organizations and build their capacity to participate in research activities and using the results f health services research. The aims are: The conference is an excellent opportunity to disseminate findings from our AHRQ-funded project, Evaluating a Comprehensive State-Level Model to Improve Nursing Home Quality, by opening up a dialogue with other states and leading researchers in long-term care. The aims of the conference are to: Examine the state of the art in LTC Value Base Purchasing program design, funding, performance measurement, and evaluation; Share and document experiences of states that have undertaken LTC VBP programs and researchers who have studied these programs; Promote an active dialogue among conference participants, including states that seek to develop new LTC VBP programs; and Prepare a report for publication that summarizes conference proceedings and can serve as a resource for LTC VBP development or refinement.

Public health relevance
PUBLIC HEALTH RELEVANCE: We will sponsor a one and one half day, national conference on incentivizing better long-term care quality for 50-75 invited state policy makers, long-term care researchers, and other stakeholders. The conference will examine the state of the art in value base purchasing program design, funding, performance measurement, and evaluation. States that have undertaken nursing home value based purchasing programs will have an active dialogue with researchers who have studied these programs; the conference will result in a report that summarizes the proceedings.